PPARa and related nuclear receptors in non-alcoholic fatty liver disease

PROJECT SUMMARY/ABSTRACT
The epidemic of obesity and type 2 diabetes has increased prevalence of associated cardiometabolic diseases
including elevated serum triglycerides (TGs) and non-alcoholic fatty liver disease (NAFLD). There is resurgent
interest in drugs targeting the hepatic nuclear receptor PPARα. Such fibrate drugs are already used in
hypertriglyceridemia, and there is new appreciation that TGs independently cause atherosclerotic cardiovascular
disease such that lowering TGs reduces risk. Furthermore, PPAR agonists may be among the first drugs
approved for NAFLD. Adverse clinical outcomes in NAFLD like cirrhotic liver failure, hepatocellular carcinoma,
and liver-related death are all closely linked to hepatic fibrosis. Our preliminary data in a NAFLD mouse model
show unexpectedly that PPARα deficiency and PPARα agonist treatment both fail to change hepatic steatosis,
but markedly affect fibrosis (increasing and decreasing it, respectively). PPARα functions in hepatocytes to bind
regulatory DNA and affect expression of key genes in lipid metabolism. The related nuclear receptor HNF4α is
not a drug target, yet regulates similar genes and binds similar regulatory DNA. We hypothesize that the interplay
of PPARα and HNF4α in DNA binding affects hepatocyte gene regulation, relevant to the pathogenesis and
therapeutics of NAFLD. Our experiments probe genome-wide nuclear receptor binding sites and gene regulation,
in normal and steatotic livers, basally and in response to drugs. Aim 1 defines the interdependency of PPARα
and HNF4α in liver gene regulation, using mouse models deficient in either or both. Aim 2 extends these studies
of PPARα and HNF4α to NAFLD, in both mouse models and human biospecimens. Aim 3 deploys the powerful
tools of genetics to characterize PPARα and HNF4α interplay in sequence-specific DNA binding. By comparing
inbred mouse strains, natural polymorphisms affecting binding motifs will reveal mechanisms for selective and
common DNA binding by PPARα and HNF4α. In human liver samples, we will test the hypothesis that that non-
coding genetic variants in PPARα/HNF4α genomic binding sites underlie some differences among people in TG
levels, NAFLD, and response of these to PPARα agonist drugs. Beyond this potential clinical relevance, these
studies use innovative genomic and genetic approaches to address key unanswered questions in the biology of
PPARα, including its interplay with related nuclear receptors.

Public health relevance
PROJECT NARRATIVE This project focuses on PPARα, a key regulator of fat metabolism in liver cells, and how it and the related factor HNF4α impact non-alcoholic fatty liver disease (NAFLD), a growing threat to public health related to the epidemics of obesity and diabetes. There are no drugs approved for NAFLD, but those targeting PPARα are strong candidates to be among the first. By using mouse and cell models as well as human liver samples, our genomic and genetics studies will reveal mechanisms of PPARα function related to the pathophysiology and treatment of NAFLD.